Medgar Evers/Kingsborough Bridge Program

The Medgar Evers/Kingsborough Bridge Program will continue to upgrade an educational environment and mechanism to increase the number and quality of undergraduate students completing an Associate Degree in Science who continue to the Bachelor's level with an ultimate aim of entering a career in biomedical research. The transitionperiod between completing the A.S. degree and entering into a B.S. degree program can be a serious stumbling block, impeding the progress of well qualified and potentially successful students who continue to be grossly underrepresented in the fields of biomedical research. Our aim is to actively promote the academic success of students from the targeted areas by providing a five year long intervention and enrichment program using the combined resources of Medgar Evers College and Kingsborough Community College, both of which are located in Brooklyn, NY. The program will promote student interest, excitement and ability to pursue biomedical studies; student awareness of the accessibility of biomedical careers through continuation of their education; improve student verbal, written, mathematical and social skills to provide them with the basics to successfully pursue biomedical careers; promote student realization of the relationships of biomedical studies to all aspects of their lives because the biomedical sciences are a major driving force in society; and provide a smooth transition into a senior collegefor students graduating from Kingsborough CommunityCollege. Toachieve this and better prepare students, who will be the next generation of biomedical researchers, Medgar Evers College and Kingsborough Community College will continue their academic partnership to improve the already good relationship, strengthen all meaningful components of our programs and initiate innovative strategies.

Public health relevance
The Medgar Evers/Kingsborough Bride Program has direct relevance to public health in so far as it will be a prime education conduit for a future generation of biomedical research scientists. The research training and projects that will be undertaken during the time period of the project are biomedically oriented. The students will be grounded in research trainingand go on the graduate schools and beyond to conduct biomedically relevant research.